Testing Implementation Strategies to Scale-up a Multicomponent Continuum of Service Intervention for Families Involved in Systems with Parental Opioid and Methamphetamine Use

PROJECT SUMMARY/ABSTRACT
Nationwide, 2023 saw a 9.5% increase in reports to child welfare (CW), with the majority related to parent
drug use. This was notably true in Oregon, where the increase in the number of reports exceeded 13%. While
2024 saw an overall decrease in predicted annual overdose deaths nationally, Oregon’s predicted rate increased
to a record high. Parents referred to CW experience a range of system interventions across the sequential
intercept model, from diversion to preventive services, to child removal into foster care, and reunification and
community monitoring. Along this intercept, parents are referred for services, including substance use and
mental health treatment, parent training, and other social determinant of health needs. Families living in rural
counties with limited treatment options experience myriad barriers to accessing treatment and exiting the system.
Just Care for Families (JCFF) is an emerging practice for parents intersecting with CW developed to address
their interrelated substance use, mental health, parenting, community building, navigating systems, and basic
treatment needs. JCFF has been implemented in five rural Oregon counties with the opportunity to expand into
others. Current implementation challenges, including travel distance in large rural counties and lack of a JCFF
Expert workforce to support implementation, limit JCFF’s current scalability.
This Hybrid Type II effectiveness-implementation trial uses an adaptation of a stepped-wedge design to test
clinical outcomes spanning interception points with the CW system and implementation outcomes when JCFF
is delivered with the addition of a mobile App with provider feedback about parent App usage. Nine rural Oregon
counties, five active counties previously implemented with developer support, and four new counties that will
implement with new JCFF Expert support have been recruited to test the (Aim 1) clinical effectiveness of JCFF
when delivered with and without the App. A total of 254 parents with opioid and/or methamphetamine use and
intersection with the CW system will be recruited to participate. Parents will receive usual services, JCFF, JCFF
with the App, or JCFF with the App and feedback. Longitudinal in-person assessments at baseline, 4-months,
9-months, 14-months, and 18-months, and weekly text assessments of social determinants of health needs and
CW intersection will test the overarching primary aim of reduction in parent opioid and methamphetamine use
over time with increased treatment engagement, retention, completion and decreased length of CW case, re-
entry into treatment, and recidivism (arrest, CW re-referral). The (Aim 2) effectiveness of the JCFF
implementation approach will be tested when implemented with the support of new JCFF Experts versus
developer Experts, with the aim of equal effectiveness. Clinical and implementation outcomes will be modeled
(Aim 3) to examine the impact that adding the App could have on program sustainment for rural programs,
expanding the potential for JCFF to scale up in Oregon and elsewhere, positioning for public health impact.

Public health relevance
PROJECT NARRATIVE Parents involved in child welfare systems with opioid and methamphetamine use have children at particular risk for placement into foster care, and parents living in rural environments have limited access to the treatment needed to prevent this outcome. The multi-level, multi-component Just Care for Families program offers treatment tailored to parents involved in the child welfare system. The addition of a mobile app will be tested as a support for parents and providers in rural counties to assess its impact on program delivery, capacity, and clinical outcomes and prepare Just Care for Families for larger scale-up and public health impact.